Sustainable biocatalytic generation of bioactive tropolone natural products

PROPOSAL SUMMARY
For years, nature has been the source for health remedies in traditional medicine, using plants and fungi for their
curative benefits for over 2000 years. We can now attribute the benefits of these traditional treatments to natural
products generated in their biosynthetic pathways. Moreover, natural products have been a consistent source of
inspiration and resource in the development of alternative therapeutics. However, studies show that there is a
gap in knowledge on these alternatives which is rooted in a lack of evidence-based information on their efficacy,
hindering their application in mainstream medicine. Therefore, it is imperative to develop strategies that could
allow to reach the valuable molecules that give these sources their medicinal power. A subset of natural products
contains tropolone rings in their structures and have shown to have great therapeutic potential for treating cancer,
malaria, bacterial and fungal infections as well as cardiovascular, renal, and inflammatory diseases. The
tropolone moiety commonly acts as a pharmacophore, making it a valuable target to synthetically access and
evaluate. However, the complex nature of the aromatic seven-membered tropolone ring limits the sustainability
of their large-scale production, this reflected in common synthetic methods being hindered by low yields, diverse
functional group tolerance, and the need for hazardous and costly reagents. Conversely, nature has evolved
biocatalysts that enable direct routes to diversely functionalized tropolones such as the fungal α-ketoglutarate
dependent non-heme iron dioxygenase XenC, bypassing the general setbacks of traditional synthetic methods.
Nonetheless, the applicability of this enzymatic method remains hindered by the concentration of substrate that
XenC can tolerate, the required two-step reaction sequence, and the limited substrate scope that prevents the
practical applications of this approach to access a plethora of tropolone natural products. In the efforts of
improving the scalability, sustainability, and broader applicability of this biocatalytic method towards accessing
bioactive tropolones, I aim to engineer XenC into an enzyme that tolerates higher substrate loadings, works in a
sustainable one-pot cascaded at pH 8, and has a broader non-native substrate scope. The successfully evolved
enzymes and the developed biocatalytic platform will enable novel chemoenzymatic syntheses of tropolone
sesquiterpenes, fungal marine tropolones, and tropolone alkaloids, providing a scalable and sustainable strategy
that allows to reach diverse tropolones and analogs to facilitate their in-depth pharmacological studies. In turn,
this will impulse the development of novel medicine alternatives with the purpose of treating human-health
concerns including infections, inflammation, malaria, and cancer.

Public health relevance
PROJECT NARRATIVE The proposed research seeks to impact human health by enabling the synthesis of tropolone natural products and derivatives thereof. Specifically, a sustainable and scalable platform for reaching useful tropolone cores will be developed to provide access to understudied bioactive tropolone natural products. Directed evolution strategies will be used to engineer biocatalysts to have improved physical properties and to possess the substrate scope to enable access to privileged natural product scaffolds. The development of this platform will allow for deeper studies of these valuable molecules which in turn will result in further understanding of natural products and their applications as therapeutics for human diseases.